2025-2027 Missouri AFRPS Maintenance

Project Summary
Since Missouri is home to a significant percentage of the nation’s livestock and pet food
production, the regulation of animal food is of vital importance for the protection of livestock feed
and pet food consumers and producers. As evidenced by past significant feed adulteration
events, feed is an important link to the human food supply and is therefore an important element
of the human food safety equation.
The Feed and Seed Program (program) has regulatory responsibility of livestock feed and pet
food sold, manufactured, and distributed in Missouri. The program operates under the authority
of the Director of the Missouri Department of Agriculture and within the Division of Plant
Industries. The program directs the Missouri Feed Control Laboratory. The laboratory analyzes
approximately 3,000 surveillance animal food samples annually. The products represented by
these samples are produced both in Missouri and across the nation.
The program considers the implementation and maintenance of AFRPS as an important step in
fulfilling its role as a crucial and significant partner with FDA in the protection of the nation’s food
supply. The program’s intent is to utilize cooperative agreement funds to continue to meet the
critical needs of the feed program to maintain full implementation of the standards and maintain
the capacity and capability to inspect the full inventory of Missouri feed facilities for compliance.
The funding will be used in the following ways: maintain inspection strength to provide sufficient
risk-based inspections, furnish outreach to industry, sustain appropriate staff training levels,
maintain compliance and enforcement infrastructure, and improve program productivity and
efficiency in regulatory processes.
The program is committed to enhancing its cooperation and collaboration with the FDA and
other state feed programs by sharing data, best practices and processes, and actively
promoting and advancing the improvement of human and animal food safety to bring continuous
improvement to the partnership for food protection.

Public health relevance
Project Narrative Maintenance of Missouri’s conformance with the Animal Feed Regulatory Program Standards (AFRPS) PAR-25-003 of the Missouri Department of Agriculture will assist the FDA in building an integrated animal food safety system not only for Missouri but other states, as Missouri provides a significant percentage of the nation’s livestock feed and pet food. The regulation of animal food is vital for the protection of livestock feed and pet food consumers and producers. Building a quality animal regulatory program will help promote regulatory compliance and prevent foodborne illnesses in human food supply.